Research Capacity Core

PROJECT SUMMARY
The Southwest Health Engagement and Research Collaborative (SHERC) Research Capacity Core (RCC) is responsible for supporting SHERC efforts expanding the research capacity of Northern Arizona University (NAU) faculty, staff, and core research facilities to conduct cutting-edge health research. RCC will provide capacity-building resources for contemporary qualitative and quantitative data analysis methodologies, facilitate cross-disciplinary research activities, and provide capacity-building resources to NAU researchers and community partners, with a special focus on early-stage investigators. RCC’s primary function is to ensure the success of all SHERC research projects and faculty by providing access to computing, statistical, and research design expertise. RCC will also work across campus and with our collaborative partners to maximize the potential for multidisciplinary collaborations that address ongoing and emerging health issues in the southwestern United States (US). The specific aims of the RCC are to: (1) renovate the NAU’s computational core facility; (2) sustain and expand the new Technical Assistance Group Service Center (TAG-SC), which provides support for qualitative and quantitative research methodology, community-engaged research design, specialized laboratory techniques, statistics, bioinformatics and/or health informatics, and other data science methodologies; (3) continue to enhance the successful RCC Methodological Dissemination Program by providing leading-edge expertise, training, and collaborative opportunities for innovative health-related research development with an emphasis on enhancing multidisciplinary team science approaches and community-engaged research; and (4) expand the RCC Capacity Enhancement Program to support equipment, data, and computing resource acquisition and maintenance. RCC resources include: (1) personnel with expertise across the spectrum of translational research methods and statistics, development, and computation/data analysis services for multidisciplinary health research projects and programs; (2) access and enhancement of computing and laboratory facilities that focus on multidisciplinary research programs to address the need for positive health outcomes; (3) a rapidly developing health informatics infrastructure; and (4) a set of strong community partnerships that support the overall mission of SHERC.